Contemporary Human Models of Postoperative Pain: A Biopsychosocial Investigation in General Surgery

Project Abstract
Postoperative pain occurs in 80% of patients undergoing surgical procedures, with nearly 90%
of these patients reporting moderate, severe or extreme pain1,2. Despite the attempts to
understand and prevent severe pain after surgery, the percentage of patients who still suffer has
remained unchanged for over 30 years4. For most patients, acute pain peaks between 24 and
48 hours after an operation6 and remits as the tissues heal, but for some patients, this
unpleasant sensory and emotional experience can persist for months or even years7.
Postoperative pain is complex and multifaceted, however, It has been suggested that if risk
factors (biological and psychosocial) associated with chronic pain are recognized early in the
preoperative period, then a patient is less likely to develop chronic postoperative pain (CPOP)5.
Though preclinical pain models have provided evidence for some of the processes that might
underlie the chronification of pain, postoperative pain in humans is complex and remains poorly
understood10. General surgery provides a unique opportunity for researchers to examine the
potential underpinnings of this transition (via human/clinical model) in a relatively controlled
environment (I.e., operating room with procedures that are standard for specific operations).
Thus, the proposed projects will employ the use of the biopsychosocial model, in the
perioperative setting, to gain a deeper understanding of mechanisms that underlie nociception
and the pain experience in humans. This will be achieved by examining aspects of endogenous
pain modulation/ pain neurocircuitry (using quantitative sensory testing to assess diffuse
noxious inhibitory control and pain facilitation), blood-based biomarkers (cytokines, chemokines,
acute-phase reactants, pain-relative hormones, etc.) as well as relevant psychological features
and social determinants of health (using standardized psychosocial and demographic
assessments) in the preoperative setting that could potentially be used to predict which patients
might experience more severe, frequent, and disabling pain in the postoperative setting and
during other phases of recovery (follow-up). We will also examine biological markers in the
immediate postoperative phase to assess immune response to surgical insult/injury. We
anticipate that our work will ultimately identify novel biological and psychological correlates of
postoperative pain that can be used to improve risk stratification and inform treatment decisions
for patients who suffer from CPOP.

Public health relevance
Project Narrative Though preclinical pain models have identified some of the processes potentially involved in the chronification of pain, postoperative pain in humans remains poorly understood. General surgery provides a unique opportunity for researchers to examine the potential underpinnings of this major clinical concern (via human/clinical model) in a relatively controlled environment (I.e., operating room with procedures that are standard for specific operations). Thus, the proposed projects will employ the use of the biopsychosocial model, in the perioperative setting, to gain a deeper understanding of mechanisms/factors (biological, psychological and social determinants of health) that underlie nociception, the perception of pain, and the acute to chronic pain transition in surgical patients.